SARS-CoV-2 DISEASE SURVEILLANCE

This proposal aims to further the development of an advanced telemonitoring and assessment platform that will enable the digital modernization of point-of-care diagnostics, disease surveillance, and healthcare screening for SARS-CoV-2.